Core C: Data Management Core

PROJECT SUMMARY – DATA MANAGEMENT AND STATISTICAL CORE (CORE C)
Efficient, clean, and organized data, together with valid, flexible, and reproducible statistical design and analysis
techniques, are an integral component to achieving the scientific mission of the UCI ADRC. Our overarching
goal in the Data Management and Statistical Core (DMSC) is to provide logistical and intellectual support to all
ADRC investigators at all phases of scientific projects. The DMSC has a history of leading the way in
methodologic development and application of analytic techniques for the analysis of AD/ADRD data and we will
continue to lead in the coming cycle. DMSC faculty and staff will be intimately involved in the conception, design,
implementation, analysis, and reporting of research conducted by members of the ADRC. The DMSC
emphasizes regular communication with ADRC investigators and proactive involvement in ADRC-sponsored
projects. In the coming cycle, we will develop and implement continuous integration and continuous deployment
workflows for ADRC-derived research projects, enhance our ability to implement Application Program Interface
(API) procedures for ADRC projects, and develop novel statistical methodology for generalizable, reproducible,
and robust causal inference in AD/ADRD research. These DMSC-specific research endeavors will increase the
intellectual contribution of the DMSC to the scientific community at large, and will also lead to improved methods
for collecting, entering, and analyzing complex data obtained through local ADRC projects.